Aldh2 and epithelial homeostasis and pathobiology

PROJECT SUMMARY
Alcohol consumption is a major risk factor for both head-and-neck and esophageal squamous cell carcinomas
(SCCs), which are both lethal and globally prevalent. The lethality of these cancers may stem from cancer cells
exhibiting high CD44 expression (CD44H), which can survive genotoxic stress and drive tumor initiation,
invasion, metastasis, therapy resistance and poor prognosis. Acetaldehyde, a major EtOH metabolite, is a potent
inducer of DNA interstrand crosslinks (ICLs). ICLs can also arise from cancer-specific processes such as
hyperactive DNA replication and cisplatin-based chemotherapy. CD44H cells can tolerate both EtOH and
cisplatin exposure. Our preliminary data suggest that ICLs accumulate in oral and esophageal preneoplasia
(PreN) and SCC lesions, both of which are recapitulated in patient- and murine-derived organoids (PDO and
MDO, respectively), and that these cells display activation of the Fanconi Anemia (FA) pathway, which is
responsible for ICL repair. CRISPR-mediated genetic depletion of FA pathway member FANCT, a druggable
ubiquitin E2 ligase of the FA pathway, impairs formation of SCC, but not normal MDO. Moreover,
pharmacological FANCT inhibitor kills SCC cells, but not normal cells in PDO. In organoids with dysfunctional
aldehyde dehydrogenase (Aldh)-2, a mitochondrial enzyme linked to activation of FA pathway, exposure to EtOH
gives rise to enrichment of CD44H cells, which in turn survive EtOH-induced mitochondrial damage and oxidative
stress via autophagy, a cytoprotective mechanism responsible for removing damaged mitochondria and reducing
reactive oxygen species (ROS). Inhibition of both the FA pathway and autophagy may offer a novel therapeutic
approach for the selective sensitization of CD44H cells to ICL-mediated cell death by cisplatin. The overall
objective of this renewal application is to further elucidate the mechanism of how CD44H cells survive ICLs
accumulation, which promotes cell death if left unrepaired. The central hypothesis is that CD44H cells survive
via FA pathway-mediated ICLs repair and autophagy, which may present a potential cancer cell-specific
vulnerability. We will test our hypothesis by pursuing the following interrelated Specific Aims: (1) To determine
how alcohol and ALDH2 dysfunction promote genotoxicity in PreN and SCC lesions; (2) To elucidate how the
FA pathway facilitates alcohol-mediated SCC progression; (3) To delineate how CD44H cells survive alcohol-
driven ICL burden in PreN and SCC lesions. The present proposal will make use of genetically engineered mice,
MDO, PDO and xenograft tumors. We have built a comprehensive platform for development and validation of
novel translational applications to target the FA pathway and autophagy in PreN and SCCs. Our innovative
approaches will reveal novel insights about the role of alcohol metabolism in malignant transformation of head-
and-neck and esophageal epithelial cells with a therapeutic implication. These findings have the potential for
direct clinical impact in SCC and other alcohol-related cancers.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because a detailed understanding of the role of Aldh2 and alcohol-induced epithelial cell injury will fundamentally advance the fields of alcohol-related diseases, both benign and malignant. The proposed model systems and findings will provide a platform for new avenues of translational applications related to head-and-neck and esophageal squamous cell carcinomas and other alcohol-induced human pathologies. Thus, the proposed research is relevant to the NIH's mission that pertains to developing fundamental knowledge that will help to reduce the burden of human diseases.